The mechanism of the beta-lactam resistance in Staphylococcus aureus

Project Summary
Cell-wall targeting beta-lactam antibiotics are the largest group of antibacterial agents and have been the
mainstay for treatment of bacterial infections. However, most beta-lactam antibiotics cannot be used for the
treatment of methicillin-resistant Staphylococcus aureus (MRSA) infections because MRSA produces a cell-
wall synthesis enzyme PBP2A, which most beta-lactams cannot inactivate. Although PBP2A is the primary
determinant of MRSA beta-lactam resistance, the overall beta-lactam resistance of MRSA is affected by
additional bacterial factors such as FtsH, a protease in the cell membrane. Overexpression of FtsH makes
MRSA sensitive specifically to beta-lactams. The beta-lactam-sensitizing effect of FtsH is due to its
degradation of YpfP, an enzyme synthesizing the anchor molecule for lipoteichoic acid (LTA). The YpfP-
degradation by FtsH causes the production of abnormally large LTA. On the other hand, increased production
of normal LTA by deletion of the ftsH gene makes MRSA more resistant to beta-lactams. When the production
of normal LTA is suppressed by inhibiting the production of the LTA synthesis enzyme LtaS, MRSA becomes
hypersensitive to beta-lactams. Based on these results, this study hypothesizes that the large LTA lowers
MRSA beta-lactam resistance by suppressing the enzyme activities of the cell-wall synthesis enzymes
whereas the normal LTA is required for them. Even under the beta-lactam sensitizing conditions, MRSA can
regain resistance to beta-lactams. Genome-sequencing of 26 such mutants showed that 16 genes are critical
for MRSA beta-lactam resistance. The long-term goal of this project is to develop novel β-lactam potentiators
against MRSA. The objective of this study is to understand how FtsH and the disturbance in LTA synthesis
sensitize MRSA to β-lactams, and how MRSA regains β-lactam resistance. In aim 1, with the MRSA strains
producing either the large LTA or reduced amount of the normal LTA, the cell wall synthesis steps affected by
the LTA molecules will be determined. The effect of LTA on cell wall synthesis will be directly tested by a
peptidoglycan-synthesis assay. Also, the bacterial two-hybrid analysis will determine whether the degradation
of YpfP is modulated by FtsH-binding proteins. In aim 2, by generating each of the resistance mutations in the
chromosome of MRSA, the mutations critical for MRSA β-lactam resistance will be determined. Also,
transposon-mediated mutagenesis will identify the genes essential for MRSA to regain the β-lactam resistance.
Finally, to test whether the roles of the 16 genes are universally conserved among S. aureus strains, resistant
mutants will be identified from two more MRSA strains, and their genomes will be sequenced. Completion of
this study will reveal the intricate network of the beta-lactam resistance regulators in MRSA and open the door
to developing novel beta-lactam potentiators with minimal risk of resistance development in the treatment of
MRSA infections. Such drugs are expected to reduce the burdens of antibiotic resistance.

Public health relevance
Project Narrative Beta-lactams, the largest group of antibiotics, are not effective in treating infections by methicillin-resistance Staphylococcus aureus (MRSA). However, MRSA can be sensitized to beta-lactams either by activation of the membrane-bound protease FtsH or by disruption of lipoteichoic acid synthesis. Identification of the molecular mechanism underlying the beta-lactam sensitizing effects will lead to the development of novel beta-lactam potentiators, which will revive the usage of beta-lactams in the treatment of MRSA infections and reduce the burdens of antibiotic resistance.